Role of ASIC1a activation in ECM associated brain injury and mortality

Abstract
Cerebral malaria (CM) is a potentially lethal complication of Plasmodium falciparum infections particularly in
children <10 yrs of age. Globally, about 500,000 people die of severe malaria of which 30% is attributed to
CM. 30% of CM patients fail to survive and 10% of survivors develop neurological complications despite
antimalarial therapy. Malaria-induced CNS inflammation, tissue damage and acidosis significantly contribute to
CM mortality and posttreatment neurological complications. Thus, effective treatment of CM will require both
antimalarial and adjunctive therapy to target these factors. Our long-term goal is to elucidate the molecular basis
for the underlying pathogenesis of CM-mediated neurological complications and find adjunctive interventions
beyond destruction and elimination of parasites in circulation. Ongoing research for therapeutic agents that block
malaria-induced CNS inflammation, tissue damage and acidosis in experimental CM (ECM; P. berghei ANKA in
C57BL/6) associated morbidity and mortality identified three promising agents: a Statin (Atorvastatin), a
neuropeptide (Neuregulin-1), and an inhibitor of acidosis-mediated activation of acid-sensing ion channel 1a
(ASIC1a), which is the focus of this application. ASIC1a is the key proton receptor expressed primarily in neurons
of mammalian nervous systems, which mediates acidosis-induced injury of CNS neurons to ischemia. The
objective of this application is to investigate the role of ASIC1a activation in the pathogenesis of CM and to
establish this channel as a novel target for future therapeutic interventions. The central hypothesis is that
ASIC1a activation by acidosis in late-stage ECM contributes significantly to ECM associated brain injury and
mortality. A corollary to this hypothesis is that inhibition/deletion of ASIC1a will protect against ECM associated
brain injury and mortality. We have generated exciting preliminary data showing that ASIC1a is up-regulated by
P. berghei ANKA infection and that inhibitors of ASIC1a extend survival beyond usual timeframe in the absence
of antimalarial treatment. With a joint team of investigators with extensive experience in murine ECM model,
proteomics, genomics, and neurophysiology, etc., we are well positioned to successfully perform the experiments
described in this proposal.
Specific Aim 1: Determine the role of ASIC1a gene in ECM pathogenesis.
We will test the hypothesis that deletion of the ASIC1a protein will reduce ECM-associated brain injury and
mortality or extend survival during ECM pathogenesis.
Specific Aim 2: Assess the protective effects of ASIC1a inhibition against ECM-induced brain tissue
damage, altered BBB integrity and neurobehavior deficit with or without anti-malarial agent Artemether
(ARM).
We will test the hypothesis that adjunctive treatment with ASIC1a inhibitors reduces ECM-associated brain
injury and mortality.

Public health relevance
The overall goal of this application is to identify new target and develop new therapeutic strategies to ameliorate cerebral malaria-mediated brain injury and mortality. Completion of the proposed multidisciplinary/collaborative pilot project will significantly advance our knowledge and understanding of the disease and provide new direction for therapeutic interventions.